FY23. TO5. NIDA PHARMACOKINETIC ANALYSIS RESOURCE CENTER. 01/18/2022 - 04/16/2024. NIDA REF. NO. N01DA-19-8947.

Substance Misuse
The purpose of this task order is to provide clinical support for a multicenter Phase 3 clinical trial of an investigational combination for the treatment of methamphetamine use disorder.